Meiotic Chromosome Synapsis and Recombination in Yeast

DESCRIPTION (provided by applicant): We investigate the ways in which homologous chromosomes communicate with one another, via recombination and recombination-mediated whole chromosome pairing during meiosis. Recombination is studied in budding yeast with respect to the processes that ensure occurrence of interactions between homologous chromosomes, rather than between sisters as during mitotic recombination, and with respect to the nature of homology searching by an initiating double-strand break (DSB). Recombination- mediated whole chromosome pairing is studied in the filamentous fungus Sordaria. Our studies will address the possibilities of long-range contacts, per-chromosome pairing, interference/communication among developing interhomolog interactions and the roles and interactions among dynamic movement and recombinosome-mediated effects during the resolution of chromosomal entanglements that arise during pairing. We will also determine the molecular natures of genetically-identified DSB/early recombination proteins in this organism. We also investigate how chromosomal events can occur in an evenly-spaced pattern without direct genetic specification of position, using as a model system the patterning of crossover (CO) recombination events along meiotic chromosomes. We will further investigate specific issues in this field by quantitative modeling. We will continue our analysis of CO patterning in wild type and mutant strains of budding yeast and phenotypic and biochemical analysis of the roles of specific molecules of interest. We will also explore how chromatin expansion/contraction status varies globally, in temporal correlation with meiotic stages, and locally, in spatial relation to positions of CO sites. This analysis will include studies of mutants of interest in budding yeast and isolation and characterization of new relevant mutants in Sordaria. Finally, we study recombination-independent homologous pairing, a process whose mechanistic basis remains an important mystery. We will analyze our recently-described in vitro DNA/DNA pairing process. In parallel, we will further examine pairing in vivo in budding yeast. We will also further investigate a phenomenon of filamentous fungus Neurospora that appears to involve direct DNA/DNA pairing.

Public health relevance
Meiosis is the specialized cellular program that yields gametes for sexual reproduction. Interactions between homologous chromosomes lie at the heart of the meiotic program and our research addresses three aspects of this inter-homolog interaction program. Certain defects in this program result in chromosome mis-segregation, which, in turn, accounts for many important genetic diseases. Other defects result in sterility. Advances in fundamental understanding of meiotic inter-homolog interactions will ultimately have implications for diagnosis and, hopefully treatment of diverse reproductive defects.